The Role of PPM1D in Myeloproliferative Neoplasms

Myeloproliferative Neoplasms (MPNs) are chronic hematologic disorders that are associated with significant
morbidity and mortality and have the potential to progress to myelofibrosis and a blast phase. These diseases
are characterized by a series of driver mutations that originate at the hematopoietic stem cell (HSC) level,
however, the mechanisms driving disease progression are currently unclear. Current therapeutics for MPNs
largely do not alter the disease course and it is therefore imperative to decipher the mechanisms underlying
progression in order to identify new, more effective therapeutic agents. This proposal focuses on elucidating
the role of Phosphatase Mg2+/Mn2+ Dependent 1D (PPM1D) in MPNs and evaluating it as a potential target to
prevent MPN disease progression. PPM1D is involved in the maintenance and differentiation of HSCs and has
recently been found to be mutated and/or overexpressed in a subset of MPN patients. Preliminary data shows
that PPM1D mutation/overexpression leads to increased fitness of the JAK2 mutated MPN clone and that
PPM1D inhibition depletes MPN HSCs. To further discern the consequences of dysregulated PPM1D in MPNs
we will complete the following aims utilizing a multipronged approach involving primary MPN samples, human
induced pluripotent stem cell (iPSC) lines and murine models: (1) Delineate the effects of PPM1D
dysregulation on molecular signaling in JAK2V617F+ human hematopoietic cells, (2) Assess the in vivo
consequences of PPM1D overexpression on MPN disease phenotype, (3) Identify therapeutic vulnerabilities of
MPN cells with dysregulated PPM1D function. Experiments will employ a variety of techniques including
biochemical assays, murine transplant models, primary hematopoietic cell colony assays, RNA sequencing
and genotyping of transcriptomes. This proposal will also evaluate a novel strategy to target PPM1D in MPNs.
Dr. Bridget Marcellino, an assistant professor at the Icahn School of Medicine at Mount Sinai, will be
completing these studies under the mentorship of Dr. Ronald Hoffman, a scientific leader in the field of MPNs.
She will have 75% of protected research time and will be provided the necessary resources to complete these
studies. As an institution Mount Sinai is ideal for fostering the development of physician-scientists with
academic seminars and state of the art facilities and resources. Bridget will also have an advisory committee
consisting of Dr. Eirini Papapetrou at Mount Sinai, Dr. Ross Levine at Memorial Sloan Kettering Cancer
Center, Dr. Dan Avi Landau at Weill Cornell Medical College and biostatisticians, Dr. Amylou Dueck and Heidi
Kosiorek at Mayo Clinic. The career development plan outlined here will allow Dr. Marcellino to gain scientific
expertise as well as increase her skills in manuscript and grant preparation. This proposal will facilitate Dr.
Marcellino to achieve both her short term goal of publishing her findings and her long term goals of developing
as a physician-scientist and establishing an independent research program focused on identifying novel
therapeutic targets in MPNs.

Public health relevance
Project Narrative Myeloproliferative Neoplasms (MPN), namely polycythemia vera, essential thrombocythemia and myelofibrosis (MF) are chronic hematologic diseases that arise from a malignant hematopoietic clone and have the potential to progress to more overt phases of MF and MPN-blast phase, which both have limited treatment options and portend a poor prognosis. A subset of MPN patients have an activating mutation and/or overexpression of PPM1D, a serine-threonine phosphatase, which has been implicated in promoting clonal stem cell fitness. This proposal through a multipronged approach utilizing mouse models, patient-derived induced pluripotent stem cell (iPSC) lines and primary specimens from MPN patients will elucidate the role of PPM1D in MPNs and investigate its potential as therapeutic target using a novel PPM1D degrader.